CLEC7A in microglia biology and Alzheimer's disease

ABSTRACT
The C-type lectin receptor CLEC7A has recently been identified to be one of the most highly upregulated
molecules expressed by microglia in various neurodegenerative disorders, including Alzheimer’s disease. Yet,
little is currently known about the role of CLEC7A in neurodegenerative disease pathogenesis. CLEC7A is best
known for its critical involvement in the mounting of protective immunity to fungal infections. CLEC7A aids in the
elimination of fungal pathogens by promoting the induction of phagocytosis as well as coordinating the production
of proinflammatory cytokines and reactive oxygen species. More recent studies have also shown that CLEC7A
can respond to self-derived molecules such as annexins expressed by dead cells. However, in contrast to the
pro-inflammatory effector responses generated following CLEC7A detection of fungi, engagement of CLEC7A
by endogenously-derived molecules has largely been shown to trigger anti-inflammatory and tolerogenic immune
responses. In our preliminary studies, we found that deletion of CLEC7A in the 5xFAD mouse model of
Alzheimer’s disease leads to increased mobilization of microglia to amyloid beta (A) plaques, decreased levels
of A deposition, and improved neuronal health. In contrast, we find that inducing overt activation of CLEC7A
signaling via hippocampal injection of a fungal-derived CLEC7A agonist boosts A clearance and microglial
activation in 5xFAD mice. Given these collective findings, we hypothesize that the effects of CLEC7A on
microglial function and A control are ligand-specific, where endogenously-derived CLEC7A activators
generated in A amyloidosis can suppress beneficial microglial responses and fungal-derived CLEC7A agonists
can conversely promote microglial activation and A clearance. To test this working hypothesis, we will first
thoroughly define how germline ablation of CLEC7A affects Alzheimer’s-related disease progression in the
5xFAD mouse model (Aim 1). We have recently generated novel Clec7a conditional knockout mice (Clec7afl/fl
mice) and we will leverage this new genetic tool in Aim 2 to interrogate a microglia-specific role for CLEC7A in
controlling A amyloidosis, neuroinflammation, and brain pathology in 5xFAD mice. In our third Aim, we will
investigate the effects that various endogenous, therapeutic, and pathogen-derived CLEC7A agonists have on
microglial responses in multiple Alzheimer’s disease-related in vivo mouse models as well as in human microglia-
like cells generated from induced pluripotent stem cells.

Public health relevance
PROJECT NARRATIVE In recent years, the C-type lectin receptor CLEC7A has emerged as a widely used marker of disease-associated microglia in Alzheimer’s disease models; yet, the actual role of CLEC7A in neurodegenerative disease pathogenesis has not been studied in great detail to date. In our preliminary studies, we revealed that genetic deletion of CLEC7A in a mouse model of Alzheimer’s disease leads to greatly reduced levels of amyloid beta deposition, increased recruitment of microglia to plaques, and significantly improved neuronal health. For this project, we will leverage a unique combination of CLEC7A conditional knockout mouse strains, CLEC7A- deficient human induced pluripotent stem cell-derived microglia-like cells, and CLEC7A modulating agents to further uncover roles for CLEC7A in the regulation of microglia responses and Alzheimer’s-related disease progression.